Spatial omics technologies to map the senescent cell microenvironment

Project Summary
Extracellular vesicles (EVs) are critical mediators of intercellular communication, released by cells to transfer
bioactive molecules like RNA, DNA, proteins, and lipids. In the context of cellular senescence, EVs play a crucial
role in the senescence-associated secretory phenotype (SASP), helping senescent cells communicate with their
environment. These vesicles can induce paracrine senescence, promoting inflammation and tissue remodeling
in neighboring cells. EVs have been associated with various age-related diseases such as cancer, fibrosis, and
neurodegeneration, where their cargo, including specific proteins and RNA, can serve as biomarkers for
senescence, offering non-invasive diagnostic potential.
The project aims to profile the RNA, DNA, and protein content of EVs from human blood, focusing on markers
linked to senescence. We will isolate and sequence these molecules, particularly focusing on senescence-
related markers like LINE-1 and pro-inflammatory cytokines. By using super-resolution microscopy (STORM),
we will image individual EVs and analyze their cargo. The integration of this data with the broader benchmarking
project, which also includes lung and skin tissue analyses, will provide insights into the role of EVs in
senescence-related diseases.
In Aim 1, RNA, DNA, and protein profiling will be conducted using sequencing and immunoassay techniques,
while Aim 2 will involve imaging the content of individual EVs at super-resolution. This will help identify
senescence markers, which can be used for further clustering and analysis of EVs. The expected outcomes
include identifying enriched senescence markers in EVs and integrating this data with existing datasets to better
understand the role of EVs in cellular aging and disease progression.

Public health relevance
Project Narrative Extracellular vesicles (EVs) are key players in intercellular communication, especially in the context of cellular senescence, where they contribute to the senescence-associated secretory phenotype (SASP) and influence inflammation and tissue remodeling. This project aims to profile the RNA, DNA, and protein content of EVs from human blood, focusing on markers linked to senescence, such as LINE-1 and pro-inflammatory cytokines. By combining sequencing and super-resolution microscopy, the study will analyze individual EVs and integrate findings with broader data from lung and skin tissues to better understand the role of EVs in age-related diseases.